Role of melanopsin in outer segment renewal

PROJECT SUMMARY
The non-image-forming visual system is responsible for mediating a range of light-driven
processes, including circadian photoentrainment, the pupillary light reflex, masking, mood
modulation, and hormonal regulation. These myriad functions are thought to be primarily
mediated by melanopsin-expressing, intrinsically photosensitive retinal ganglion cells (ipRGCs).
Our previous research has demonstrated that melanopsin signaling is essential for regulating
vascular events during eye development. Melanopsin is also expressed in iris, cornea, and retinal
pigment epithelium (RPE), but physiological roles of melanopsin in non-retinal tissues are
unknown. Here, we expand on our exciting preliminary findings supporting (1) a role of
melanopsin and (2) a direct effect of the dark-light transition at light onset in photoreceptor outer
segment renewal. Outer segment renewal is a fundamental homeostatic mechanism maintaining
lifelong photoreceptor health and function in vision. New formation of outer segment disks by
photoreceptors is balanced with removal of distal tips of outer segments, a process originally
termed “disk shedding”. Recent work illustrated that disposal of distal outer segment tips requires
complex molecular collaboration of photoreceptors and neighboring RPE such that spent outer
segment tips are recognized and phagocytosed by the RPE without photoreceptor autonomous
tip shedding. RPE dysfunction including abnormal phagocytosis is associated with several retinal
diseases. Mechanistically, molecular signaling couples externalization of the “eat-me” signal
phosphatidylserine (PS) by photoreceptors precisely at distal outer segment tips to engagement
of the RPE’s phagocytic machinery. Outer segment renewal in general and both PS exposure
and RPE phagocytosis specifically follow a diurnal, circadian rhythm in entrained animals with a
burst of outer segment tip engulfment after light onset. Our preliminary data show abnormal
diurnal burst of PS exposure and attenuated RPE phagocytosis in mice with global or RPE-
specific deletion of melanopsin. Moreover, our experiments reveal a direct requirement for light in
the diurnal burst of outer segment renewal. Intriguingly, this light dependence is lost in mice
lacking melanopsin or the PS-inducer galectin-1, which in WT mice is released to the subretinal
space in a light-dependent manner. These results support a novel molecular mechanism of direct
light-sensitive regulation of outer segment renewal that was hitherto not recognized. Based on
these exciting preliminary data, we hypothesize that light-activated melanopsin signaling,
which occurs at least in part in the RPE, controls the characteristic diurnal burst of outer
segment renewal by regulating galectin-1.
Knowledge gap: Non-RGC functions of melanopsin remain enigmatic. Triggers of the diurnal
burst of outer segment renewal are not understood. This grant will fill these knowledge gaps by
exploring new cell-type specific deletion models of melanopsin combined with innovative
quantification of outer segment renewal processes in vivo and ex vivo. In this proposal, we will
identify and define the molecular links of melanopsin, light, and the molecular machinery for outer
segment renewal.

Public health relevance
PROJECT NARRATIVE The identification of cellular and molecular mediators of RPE function is critical to developing therapies and drugs to ameliorate the progressive vision loss in degenerative retinal diseases like age related macular degeneration. The proposed research is relevant to public health because of a novel function for melanopsin in RPE phagocytosis. The proposed research is relevant to the mission of the NEI because it will develop fundamental knowledge that may help reduce the burden of disease and improve the quality of life for patients with diseases like AMD.